Development and Application of PET-enabled Dual-Energy CT Imaging

PROJECT SUMMARY
Molecular imaging with hybrid positron emission tomography (PET) and x-ray computed tomography (CT) has
been widely used in clinical applications. CT in PET/CT is typically operated with a single x-ray energy to provide
anatomic localization and attenuation correction for PET. A major limitation of single-energy CT is its limited
ability to characterize tissue compositions quantitatively. Dual-energy CT (DECT) fills this gap by employing two
different x-ray energies to allow quantitative material decomposition. Combining DECT with PET may enable
PET/CT for several applications that have been hitherto impossible or less feasible due to the lack of tissue
composition information, for example, (i) for simultaneous PET and contrast-enhanced CT imaging where the
presence of contrast media may compromise attenuation correction, and (ii) for PET imaging of bone marrow
where neglecting the trabecular bone volume may underestimate tracer uptake in true bone marrow. Despite all
the clinical potential, integration of DECT with PET/CT would require either a costly scanner hardware upgrade
or a significant increase in radiation dose and scan cost. As a result, application of combined PET and DECT
imaging has been largely hampered in molecular imaging with PET/CT. The PI and team have proposed a PET-
enabled DECT imaging method. This method does not require a change of existing PET/CT scanner hardware
or increase the radiation dose but exploits the inherent annihilation-photon attenuation property of a radiotracer
to derive a 511 keV high-energy gamma-ray CT (gCT) image from a standard time-of-flight PET/CT emission
scan. The enabling technique is the simultaneous reconstruction of the gCT image from the existing PET
emission data, and the combination with low-energy x-ray CT (usually ≤140 keV) to form dual-energy imaging.
Our preliminary work has demonstrated the feasibility of this PET-enabled DECT method for quantitative material
decomposition using computer simulation and physical phantom studies. The goal of this R01 grant proposal is
to further develop, validate, and translate this method in the context of PET/CT molecular imaging. We propose
three specific aims to fulfill this goal: (1) Develop the technical approaches for gCT imaging with PET; (2)
Evaluate the PET-enabled DECT method for material decomposition in human subjects; (3) Apply the method
for metabolic PET quantification of bone marrow. Successful completion of these specific aims will establish an
innovative PET-enabled DECT imaging method with broad applicability. The enabled or enhanced ability for
quantitative material decomposition on PET/CT will open new avenues to improve molecular imaging. This
project would make a significant impact in numerous clinical applications where the characterization of tissue
composition matters, such as for bone-marrow PET/CT imaging or contrast-enhanced PET/CT in cancer, heart
disease, and aging.

Public health relevance
PROJECT NARRATIVE Public Health Relevance Statement: Molecular imaging with PET/CT has been widely used in oncology but current methods have limited ability to characterize tissue compositions quantitatively. This project develops and translates a PET-enabled dual-energy CT method to offer quantitative material decomposition on PET/CT scanners. The enabled ability will open new avenues to improve molecular imaging and would make a significant impact in numerous clinical applications where the characterization of tissue composition matters, such as for bone-marrow PET/CT imaging or contrast- enhanced PET/CT imaging.